HTS to identify compounds that increase NAD+ levels in neurons and muscle cells

Project Summary
Nicotinamide adenine dinucleotide (NAD) is a redox cofactor required by enzymes essential to energy
production and numerous other cellular processes. NAD also serves as a co-substrate for several classes
of signaling enzymes, each of which cleaves the molecule to release nicotinamide. Cellular NAD is derived
from dietary tryptophan (de novo synthesis), nicotinic acid (the Preiss-Handler pathway) or recycled from
nicotinamide via the NAD salvage pathway. NAD deficiency can be triggered by a variety of cellular
stresses, including DNA damage, and is thought to contribute to pathophysiology in a number of metabolic,
neurological, and muscular diseases: conversely, increasing NAD+ has been suggested as a promising
therapeutic strategy. Here, researchers will collaborate to develop and utilize a cellular High Throughput
Screening (HTS) assay to discover and validate small molecules that increase intracellular NAD+ levels.
These studies should identify novel small molecules with great therapeutic potential for a myriad of
neurological and muscular including brain ischemia, Wallerian nerve degeneration, misfolded prion
protein toxicity, Alzheimer's disease (AD), mitochondrial myopathy (MM), age related sarcopenia and
Duchenne's muscular dystrophy(DMD).

Public health relevance
Project Narrative Deficiency in the levels of oxidized Nicotinamide adenine dinucleotide (i.e. NAD+) is noted in a number of neurological, muscular and metabolic diseases. Conversely, increasing NAD+ has been suggested as a promising therapeutic strategy for these disorders. Here researchers will collaborate to develop a cellular HTS assay to identify and validate small molecules that increase intracellular NAD+ levels as potential therapeutic strategies for a variety of neurological and muscular diseases including disorders including brain ischemia, Wallerian nerve degeneration, misfolded prion protein toxicity, Alzheimer's disease (AD), mitochondrial myopathy (MM), age related sarcopenia and Duchenne's muscular dystrophy(DMD).